Biased Muscarinic Acetylcholine Receptor Signaling in Obstructive Lung Disease Pathology and Therapy

Project Summary
G protein-coupled receptors (GPCRs) control important airway smooth muscle (ASM) cell functions including
contraction, growth and phenotype that become dysregulated in obstructive lung diseases. Therefore, the
clinical management of obstructive lung diseases such as asthma relies heavily of drugs that are either agonist
or antagonists GPCRs. In this context, muscarinic receptor antagonists are used to relieve bronchoconstriction.
Unfortunately, these drugs have limitations with respect to efficacy, and many patients experience suboptimal
control. We have identified new, effective ligands that target the M3 muscarinic acetylcholine receptor (M3
mAChR) as a potential asthma therapy, by embracing the emerging concept of biased agonism. The
pharmacology of biased agonism is based on the discovery that GPCRs can assume multiple conformations
and interact with multiple proteins or protein complexes that transduce qualitatively different signals, and
ligands can “tune” GPCRs to bias signaling and function to one pathway or another. We propose to discern
biased signaling properties of the M3 mAChR and determine how GRK/arrestin-biased M3 signaling regulates
ASM functions relevant to asthma. We have discovered two small molecule orthosteric ligands that can bias
M3 mAChR signaling toward the GRK/arrestin signaling pathway. Our published and preliminary data indicate
that arrestin-dependent signaling mediates therapeutically beneficial ASM functions such as inhibition of ASM
cell contraction, proliferation and promotion of contractile phenotype. Supported by these observations, we
hypothesize that arrestin-/GRK-dependent signaling by the M3 mAChR in ASM mediates multiple distinct
beneficial signals and functions, and strategies that bias M3 mAChR signaling can be used to treat obstructive
lung diseases. Biased M3 ligands will be tested in cell- and tissue-based studies of ASM signaling and
function, and ultimately in an in vivo model of asthma to discern the efficacy of these biased M3 ligands as
asthma therapeutics. Aim 1 studies will employ genetic, molecular and pharmacological strategies, including
use of mice with arrestin subtype genes ablated, to establish how biased M3 ligands inhibit contractile
signaling and promote relaxant signaling in ASM. Studies in Aim 2 will focus on anti-remodeling properties of
biased M3 ligands and determine which mechanisms contribute to inhibition of ASM cell growth and
modulation of ASM to a hypercontractile phenotype. Finally, Aim 3 studies will test our biased M3 ligands in an
in vivo model of asthma to verify the ability of a biased ligand to mitigate features of allergic asthma. The
impact of the proposed studies lies in their ability to significantly advance the science underlying, and ultimate
clinical application of, biased agonism pharmacology to asthma.

Public health relevance
Project Narrative Obstructive airway diseases such as asthma and COPD are characterized by difficulty in breathing and the current bronchodilatory therapies are suboptimal in relieving bronchoconstriction. Thus, there is a pressing clinical need to discover newer and more efficient bronchodilatory therapies. Experiments are proposed to understand how the emerging concept of pharmacology of biased agonism, that recognizes the complexity by which drugs can regulate airway cell surface receptors and cellular functions, can be exploited to develop new drugs targeting M3 muscarinic receptors with better efficacy, as well as target multiple pathological processes in the treatment of obstructive lung diseases.